Translating the tumor regulome from cell-free DNA for precision oncology

PROJECT SUMMARY/ABSTRACT
Per the FOA, this section is not required. The research supplement proposal does not change the activities of
the parent award.

Public health relevance
PROJECT NARRATIVE Per the FOA, this section is not required. The research supplement proposal does not change the activities of the parent award.